Subclinical Atrial Fibrillation and Supraventricular Ectopy in the Jackson Heart Study

ABSTRACT
Atrial fibrillation (AF) is a common arrhythmia that can have devastating consequences, including
stroke and accelerated decline in cognitive function. Because AF is often asymptomatic and escapes clinical
detection (subclinical AF), conventional methods for identifying AF have underestimated the population
burden of AF. African Americans have a lower risk of clinically-recognized AF than whites, yet they suffer more
stroke and cognitive impairment. A high prevalence of subclinical AF and of another important arrhythmia,
supraventricular ectopy (SVE), may help to explain this paradox. In addition, several emerging risk factors
for AF and SVE, including long-term changes in blood pressure, hypokalemia, the use of certain medications,
and psychosocial factors, are modifiable and represent potential targets for AF prevention. The use of sensitive
and unbiased methods to detect AF and SVE, and the discovery of novel modifiable risk factors for these
arrhythmias, may offer opportunities for improved cardiovascular disease (CVD) prevention among African
Americans. Our project will use a non-invasive electrocardiographic (ECG) monitoring device that is both well-
tolerated and sensitive for detecting subclinical arrhythmia to measure subclinical AF, AF type (paroxysmal vs.
persistent), and SVE frequency. In this ancillary study, we propose to conduct 14-day continuous ECG
monitoring on 2,000 participants who return for Field Center Exam 4 of the Jackson Heart Study (JHS), a large
prospective cohort study of CVD risk factors in African Americans. We will also use data from anticipated
contract funded components of the Field Center Exam, including cognitive assessments and brain magnetic
resonance imaging (MRI). Our goals are to assess the population burden of subclinical AF and SVE among
African Americans, and to identify correlates of subclinical AF and SVE that may be modifiable risk factors or
consequences of these arrhythmias. There are four aims. Aim 1: Estimate the age- and sex-specific
prevalence of subclinical AF and AF type (paroxysmal vs. persistent) among African Americans in the JHS,
and compare with the prevalence of subclinical AF and AF type among white participants undergoing 14-day
continuous ECG monitoring in the Multi-Ethnic Study of Atherosclerosis and the Atherosclerosis Risk in
Communities Study. Aim 2: Using data from JHS Exams 1-4, (a) evaluate whether traditional AF risk factors
are associated with subclinical AF and SVE, and (b) identify novel, modifiable risk factors for these arrhythmias.
Aim 3: Evaluate the utility of a clinical AF risk score, NT-proBNP levels, and risk factors identified from Aim 2
for the prediction of subclinical AF. Aim 4: In cross-sectional analyses, determine whether subclinical AF and
SVE are associated with worse cognitive function and with brain MRI abnormalities. This project will generate
new knowledge about subclinical AF and SVE that will be relevant to patients, and that will inform prevention
and treatment strategies to reduce the burden of AF and AF-related complications among African Americans.

Public health relevance
NARRATIVE Atrial fibrillation is a common cardiac arrhythmia that often causes no symptoms but can result in devastating complications, including stroke and reduced cognitive function. Among African Americans, little is known about the true population burden of atrial fibrillation and of a related arrhythmia, supraventricular ectopy. We propose to use a novel cardiac monitoring device to accurately measure these arrhythmias in large cohort study of African Americans, and to study the relationship of these arrhythmias with new risk factors and with measurements of cognitive function and brain abnormalities.